Identifying ancestry-specific and distal components of disease-associated gene regulation and cellular function

Summary/Abstract
Genome-wide association studies (GWAS) have associated hundreds of thousands of genetic variants with
human disease and complex traits. 90% of associated variants reside in noncoding sequences that can
enhance or suppress gene expression levels. While GWAS does not reveal the target genes of associated
variants, extraordinary effort has been dedicated to mapping target genes that carry out the functional effects
of noncoding genetic variation. While knowing which genetic variants cause disease is not often sufficient for
clinical intervention, identifying disease genes can efficiently accelerate the development of therapeutics.
Correlations between genotype and gene expression, known as expression quantitative trait loci (eQTL)
studies, can provide valuable insight into the mechanism of disease-associated variants. For example, a
previous study found MAPK3 to be associated with schizophrenia and neurodevelopmental phenotypes via a
key role in neuronal proliferation. Thousands of genetic associations are still uncharacterized in terms of their
target genes and cell types of action. This proposal will develop new algorithms to robustly map disease-
associated variants to disease-critical genes and infer their cell-type-specific regulatory behavior across three
aims. First, we hypothesize that new disease-critical genes will be discovered if variants are accurately
mapped to target genes in non-Europeans, where cohorts are small and variant-to-gene mapping is imprecise.
To this end, we will develop a novel gene-disease mapping technique for understudied populations. Second,
we hypothesize that linking distal regulatory variants to target genes should provide mechanistic explanations
for many uncharacterized GWAS variants. To this end, we will develop a high-dimensional feature selection
technique to detect distal effects on gene expression. Third, we hypothesize that novel variant-to-gene links
can be identified by analyzing rare cell types from single cell RNA-sequencing. To this end, we will link variants
to genes in cell-type-specific contexts using mixed models for heritability estimation. Overall, while gene
expression prediction models are a powerful tool to link genes to disease, they have been applied to only
limited study designs: single ancestry gene expression cohorts (which are not powerful in non-European
populations with limited sample sizes), predictor variants in the cis regulatory window, and bulk tissue or cell
type gene expression data. There are many open questions due to these limitations that our proposal aims to
address including the degree to which genetic variation regulates gene expression in population-specific
manners, via long-range mechanisms, in cell-type-specific or cell-state-specific manners, and in ways that are
relevant to complex traits and diseases. Our contribution is expected to be significant because still 30% of
disease-associated variants have no known target gene and because this work will diversify genetic discovery
to populations who are most at risk.

Public health relevance
Project Narrative The proposed research will identify genes and their cell types of action driving human disease across global populations, revealing clinically relevant candidate biomarkers and drug targets while enhancing the equity of biomedical discovery. This project is relevant to the mission of the NIH because it provides a stellar return on the investment of millions of dollars allocated to variant-to-function studies by providing statistical methodology to comprehensively elucidate the functional mechanisms of disease-associated genetic variation.